High-throughput spatial proteomics in pulmonary research with FLASH multiplex imaging

Project Summary
Addressing the complexities of heart, lung, and blood disorders at the cellular and molecular level
requires a spatial omics technology capable of rapidly and reliably mapping the distribution
of specific cell markers within tissue at the subcellular scale. While spatial proteomics
technologies have revolutionized in situ molecular profiling of tissues, limitations in resolution,
throughput, sample degradation, and cost have hindered their widespread impact. This is the
focus of our project, which proposes to develop FLASH-PAINT, a disruptive proteomics
technology, into AFLEX, an automated and multiplexed imaging solution specifically tailored for
FFPE tissue samples. Our proposed technology promises to provide scientists with a simple
method to perform exceptionally rapid 32-plex protein imaging on their tissue samples
using a microfluidics chamber designed for easy integration with standard benchtop
microscopes and necessitating minimal experimental intervention on their part. AFLEX is
distinguished by its elimination of washing steps, thereby preventing sample degradation and
enabling the rapid collection of highly multiplexed imaging data of large 1 cm2 tissue sections.
Panluminate, Inc. is a leading company in the spatial proteomics space. Our proposed project
aims to develop AFLEX and validate it in human FFPE tissue. We specifically propose to (1)
develop a new concept and prototype for microfluidics tailored for FLASH samples that removes
the need of traditional large-footprint microfluidics, (2) develop new FLASH probes designed for
high signal-to-background imaging in FFPE tissue, and (3) test this system in a testbed application
of fibrotic human lung tissue. Ultimately, the developments proposed here will enable panluminate
to disseminate AFLEX imaging to every research and biotech lab around the world.

Public health relevance
Project Narrative Understanding the complex functions of normal cellular processes at a molecular level, particularly how individual cells and their microenvironment interact over time and space, will provide new insights into the cellular mechanisms disrupted in fibrotic diseases. In this project, we will develop AFLEX, the first automated subcellular spatial proteomics platform technology that is capable of multiplexed data generation on the scale of minutes versus hours, and validate its applicability in healthy and fibrotic formalin-fixed, paraffin-embedded human lung tissue. This development is crucial for advancing public health as it aims to transform the way we identify, treat, and prevent fibrotic diseases, opening new horizons in biomarker discovery and therapeutics.